Single-Cell Transcriptomics of Non-Activated Latently Infected T cells Isolated from HIV+ Drug Users

SINGLE-CELL TRANSCRIPTOMICS OF NON-ACTIVATED LATENTLY INFECTED T CELLS ISOLATED FROM HIV+ DRUG
USERS
Opioid use alters the epigenetic structure of the brain but its effects on CD4+ memory T cells, the main reservoir
for latent HIV-1, remain unknown. The central hypothesis of this application is that the identity of memory T cells
carrying latent HIV-1 is altered by opioid exposure, and thus, identifying specific biomarkers in patients with
opioid use would be valuable. This hypothesis was formulated based on published results showing that opioid
receptors are expressed on CD4+ T cells and signaling through these receptors modulates T-cell activation and
differentiation. The central hypothesis will be tested in a two-pronged, highly milestone-driven approach. In the
innovation phase (R61), our aims will optimize two necessary technologies: 1) Tracker-Cas9-Q, a new CRISPR-
based in vivo DNA-labeling technique to visualize latently infected T cells, and 2) single-cell RNA sequencing
and associated computational analysis for robust biomarker development. Aim 1: To label the HIV-1 proviral
locus in intact cells by harnessing novel CRISPR-Cas protein technologies. Tracker-Cas9-Q is a new
fluorescently labeled, but internally quenched, complex of catalytically inactive CRISPR/Cas9 and specific
CRISPR guide RNAs that only fluoresces upon DNA binding (Murthy Lab). The underlying working hypothesis
is that Tracker-Cas9-Q delivered within nanogold microparticles (CRISPR-Gold) allows efficient in vivo labeling
and flow sorting of T cell lines containing latent HIV DNA. Aim 2: To establish single-cell RNA-Seq and
computational biomarker identification in primary T cells ex vivo infected with dual-fluorescent HIV-1 with and
without opioid exposure. The transcriptome of individual cells – alone or in complex cell populations – can now
be analyzed at sufficient depth (Ott Lab) to allow reliable biomarker development in HIV-infected primary cell
populations (Yosef Lab). Our working hypothesis is that individual latently infected primary T cells can be
efficiently isolated and analyzed on a single-cell basis using RNA-Seq. In order to progress to the R33 phase, at
the end of the R61 period we will have developed an HIV-specific DNA labeling system with efficient delivery
(>50%) and sortable fluorescence intensities and established single-cell RNA-Seq and computational platforms
for biomarker development. The R33 phase has one aim combining the experimental systems from Aims 1 and
2 in primary T cells isolated from aviremic HIV+ individuals under antiretroviral therapy. Aim 3: To characterize
latently infected memory T cells at the single-cell level, isolated from HIV+ individuals with and without opioid
use, using novel CRISPR-based labeling techniques. Our working hypothesis is that the newly developed
Tracker-Cas9-Q and CRISPR-Gold technologies will efficiently label the latent provirus in patient-derived T cells,
and combined with single-cell RNA-Seq and computational biomarker analysis, will yield fundamental new insight
into the identity of latent reservoir cells in HIV+ individuals with and without opioid use. Our studies will contribute
fundamentally new technologies and translatable biological knowledge to the study of HIV latency in opioid users.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health; it will contribute novel technology to identify and characterize latently infected memory T cells in HIV+ individuals with and without opioid use, a major hurdle in the field. These results would be of substantial benefit to the field because they would vertically advance understanding of the regulation of HIV latency and provide tangible tools to define and clear latency in infected individuals. The project is relevant to NIH's mission as it fulfills one of the high-priority topics of research for support using AIDS- designated funds: research toward a functional cure.